Proteolysis in the Pathogenesis of ARDS

PROJECT SUMMARY/ABSTRACT
The Acute respiratory distress syndrome (ARDS) is the severest form of acute lung injury (ALI), and is
characterized by injury to the alveolar-capillary unit and compromised alveolar epithelial integrity, leading to
high permeability pulmonary edema and neutrophilic alveolar inflammation. Failure to repair the damaged
alveolar membrane leads to significant mortality. Studies from several laboratories, including our own, have
found that induction of ALI in animal models is associated with increased expression of matrix
metalloproteinase-3 (MMP-3), a protease that has been shown to directly target cell-cell junctions and to
degrade basement membranes, although it was unknown at what stages of ALI pathology this process was
most critical. Other laboratories and ours have also found that transgenic mice lacking MMP-3 are resistant to
lung injury induced by multiple stimuli, indicating that inhibitors of MMP-3 have potential as therapeutic agents
for ARDS, although such a therapeutic strategy would need to be highly selective, as other MMPs have been
shown to play key roles in repair of lung injury. In this translational application, we propose experiments which
will bridge these critical gaps. In Aim 1, we will use physiologically relevant cell culture and animal models of
ALI/ARDS including novel transgenic mice to define how MMP-3 affects the resolution of epithelial injury in
response to acid aspiration or influenza infection. In Aim 2, we will use our directed molecular evolution
platform to create variants of Tissue Inhibitor of Metalloproteinase-1 (TIMP-1) with greatly increased affinity for
MMP-3 and decreased binding to beneficial MMPs, and we will define the therapeutic utility of these TIMP
variants in mouse models of ALI/ARDS. In Aim 3, we will interrogate clinical samples of ARDS to determine the
precise stages of human disease progression at which therapeutic intervention would be most beneficial. Our
research proposal will define a newly-discovered mechanism by which MMP-3 drives ARDS pathology through
an integrated research plan that links single cell RNA sequencing of cell populations isolated from ARDS
patient tissue, cell culture and animal models of ARDS, and analysis of relevant ARDS biomarkers and ex vivo
culture of precision cut human lung slices, and will develop a novel selective inhibitor with immediate
therapeutic potential. Our multidisciplinary research team is uniquely suited to address these questions. Our
work will address critical mechanisms underlying ALI/ARDS, will use this knowledge to develop personalized
strategies that will identify patients at highest risk of developing ALI/ARDS, and will create therapeutic
approaches based on the pivotal role of MMP-3 in the pathogenesis of epithelial injury leading to ALI/ARDS.

Public health relevance
PROJECT NARRATIVE Through our published and preliminary data, we have identified a novel process by which expression of matrix metalloproteinase (MMP)-3 in acute lung injury/ARDS drives disease pathology. Our work will answer critical questions about why some patients resolve ARDS while others progress to life-threatening disease and by developing a therapeutic inhibitor of disease progression, as well as essential information about which patients and at what stages of disease progression therapeutic intervention will be most beneficial. Successful completion of these studies will advance our understanding of ARDS and provide a novel therapeutic approach for this devastating disorder.